Identifying Mitochondrial Mechanisms Driving Learning and Memory

Project Summary
The overall goal is to understand the energy supply mechanisms of learning and memory. The human brain is a
metabolically vulnerable organ, where even an acute interruption in energy supply leads to immediate cognitive
impairment. This energy consumption is primarily at neuronal synapses, which require energy for diverse
processes such as maintaining ion gradients, making new proteins, and transporting molecules. Because most
synapses are placed far from their neuronal cell body, mere ATP diffusion is insufficient to cope with the
immediate (minutes) and sustained (hours) energy demands of local biological processes – a local energy source
is necessary. Consistent with this notion, my lab recently showed that mitochondria are locally stabilized in
dendrites. Local impairment of stable mitochondria affects the ability of nearby spines to undergo synaptic
plasticity, the cellular basis of learning and memory (Rangaraju et al., Cell 2019, Bapat et al., bioRxiv 2023).
Therefore, spatially stable mitochondria are essential to fulfilling the constant local energy demands of synaptic
plasticity formation and maintenance. In light of our recent unpublished data, we hypothesize that mitochondria
synthesize ATP on-demand during synaptic plasticity, and the temporal and spatial coordination of mitochondrial
energy production near synapses dictates synaptic plasticity in time and space. So far, the known mechanisms
of mitochondrial energy production are primarily based on information averaged across all subcellular
compartments, but how plasticity stimuli regulate subcellular energy supply near synapses is unknown. We at
the Rangaraju Lab will discover novel regulators that dictate the flexibility of local mitochondrial energy
production in temporal (minutes to hours) and spatial (ms of dendrite) scales relevant for synaptic plasticity
formation and maintenance. To tackle this challenge, we combine recent innovations in subcellular proteomics
and CRISPR-based screening in primary neuronal cultures. In addition, we have developed state-of-the-art
methods to measure ATP synthesis and calcium handling in individual spines and mitochondria at high spatial
and temporal resolution to characterize subcellular (dendrites, spines) regulation of mitochondrial energy
production at different stages of synaptic plasticity. Lastly, we will characterize our newly identified mechanisms
in vivo in behavioral assays during various forms of learning and memory (spatial, motor, short- and long-term).
Overall, we will systematically investigate the synaptic energy logistics that allow the brain to process and store
information. As mitochondrial dysfunction is often linked to memory and cognitive impairment, filling the
knowledge gap between mitochondrial mechanisms and cognitive behaviors will provide new solutions to
learning and memory disorders.

Public health relevance
Project Narrative We aim to discover novel mitochondrial mechanisms driving learning and memory. This research will significantly impact human health as mitochondria are hotspots of dysregulation in neurodegenerative, neuropsychiatric, and neurodevelopmental diseases. Novel insights from our findings will also help develop future diagnostic and therapeutic strategies for many conditions associated with mitochondrial impairment, such as Alzheimer’s, Parkinson’s, and amyotrophic lateral sclerosis.